Modulating prostaglandin E2 receptor activity to improve pancreatic islet function

Type 2 diabetes (T2D) affects nearly 25% of US veterans and is characterized by decreased functional β-cell
mass. Individuals with T2D have increased risk for heart disease and stroke. The incidence of T2D increases
with age, in part due to a decreased ability of β cells to respond to proliferative cues as they get older.
Prostaglandin E2 (PGE2) is elevated in the setting of obesity and T2D and is associated with decreased β-cell
function. PGE2 binds four G protein-couple receptors (GPCRs) designated E-Prostanoid (EP)1-4. The incretin
GLP-1 also exerts its effects through a GPCR and agonists of the GLP-1 receptor are used to treat T2D.
However, not every patient responds positively to this class of drugs, potentially due to increased activity of
negative regulatory pathways in the β cells of these individuals. Our lab discovered that the EP3 and EP4 PGE2
receptors modulate β-cell mass dynamics. We found that pharmacological inhibition of EP3 or activation of EP4
enhances β-cell proliferation and survival in both mouse and human islets ex vivo. Thus, EP3 and EP4 play
opposing roles in β cells with EP3 inhibiting and EP4 enhancing cellular functions. In addition, our preliminary
studies in the db/db mouse model of T2D reveal that systemic treatment with EP3 antagonist enhances β-cell
proliferation and mass and reverses some of the changes in gene expression associated with β-cell dysfunction.
Multiple splice variants of the EP3 receptor exist in all species. These variants have identical ligand binding
properties, but differ in their constitutive, agonist-independent activity, with the EP3γ isoform having the most
constitutive activity in mouse. EP3 expression increases with age and T2D in mouse and human islets and
decreases in response to β-cell mitogens. In mice, we found that EP3γ is most highly upregulated with age.
Constitutively active EP3 receptor would be unaffected by strategies such as non-steroidal anti-inflammatories
(NSAIDs) that lower synthesis of the ligand, PGE2. We will use a cell-based screening strategy to identify inverse
agonists that block constitutive EP3 activity. Whole genome sequencing and proteomics will define downstream
effects of EP3 and EP4 receptor modulation in β cells of db/db mice and islets from humans with T2D. Machine
learning approaches will be used to correlate expression of PGE2/EP pathway genes with T2D patient
phenotypes and to predict patient responsiveness to GLP-1 pathway agonists. Unique Vanderbilt resources (de-
identified electronic health record and linked DNA samples) will be used to assess whether NSAID use and/or
predicted lower EP3 expression or higher EP4 expression is associated with better outcomes. We hypothesize
that increased EP3 activity impairs β-cell identity and compensation leading to decreased functional β-cell mass
and decreased responsiveness to GLP-1 receptor activation in the setting of T2D and aging.

Public health relevance
Individuals with T2D have increased risk for heart disease, stroke, and death from cardiovascular disease (CVD). The incidence of T2D increases with age, in part due to a decreased ability to expand β-cell mass. Our lab discovered that pharmacological inhibition of the PGE2 receptor, EP3, or activation of the EP4 receptor enhances β-cell proliferation and survival in mouse and human islets. Our preliminary studies in the db/db mouse model of T2D reveal that systemic treatment with EP3 antagonist enhances β-cell proliferation and mass and reverses some of the changes in gene expression associated with β-cell dysfunction. Whole genome sequencing and proteomics will define downstream effects of EP3 and EP4 receptor modulation in β cells of mice and humans with T2D. Unique Vanderbilt resources (de-identified electronic health record and linked DNA samples) will be used to probe PGE2/EP pathway genes in T2D patients and to predict responsiveness to GLP-1 pathway agonists currently used to treat T2D.